Effects of prenatal and postnatal cannabis use on Lactation And Maternal Bonding (LAMB)

Cannabis use in pregnancy and the postpartum period is common. Although many current studies are focusing
on the potential neurodevelopmental consequences of in-utero exposure, there is a paucity of knowledge
regarding the potential effects of cannabis use in the postpartum period.
Given that cannabis metabolites effect dopamine release in the brain’s reward center, it is biologically plausible
that cannabis use could alter the positive reinforcement that mothers get from interaction with their infants,
therefore effecting their behavior. Pre-clinical data has shown differences in maternal behavior after cannabis
consumption. Studies in humans have also shown a notable difference in maternal neurotransmitter release in
response to their infants when comparing mothers who use substances of abuse and those who do not.
After birth, infants may also be directly exposed to cannabis metabolites through breastmilk. Studies have
shown that active cannabis metabolites concentrate in the breastmilk of humans. However, the absorption and
effects of these metabolites have not yet been studied. Given the known benefits of breastmilk, no
recommendation currently exists to discourage the practice in lactating people who use cannabis.
In this study, we intend to 1) evaluate associations between cannabis use and prenatal maternal attachment,
2) evaluate associates between cannabis use and postpartum maternal bonding and self-efficacy and 3)
quantify transfer of cannabis metabolites through breastmilk consumption.
Our study includes two separate but related cohorts: First, a cohort of 800 pregnant people who will be
followed prospectively from the third trimester of pregnancy through 8 weeks postpartum. Of these, 600 will
have used cannabis at some point in their pregnancy and 200 will not have used cannabis during pregnancy or
postpartum. They will complete the Maternal Antenatal Attachment Scale in their third trimester of pregnancy
and the Postnatal Bonding Questionnaire and Perceived Maternal Parenting Self-Efficacy Tool at eight weeks
postpartum. Scores will be compared between four groups 1) never used cannabis 2) used cannabis during
pregnancy and postpartum 3) used cannabis but quit during pregnancy, returned to use postpartum 4) used
cannabis but quit during pregnancy and did not return to use postpartum.
The second cohort will consist of twenty breastfeeding mothers who have made the personal decision to use
cannabis during breastfeeding and ten who do not use cannabis. Maternal and infant blood samples and
breastmilk samples will be collected and analyzed to evaluate the transfer of cannabis metabolites from
breastmilk to the infant.
The results of this study will fill a knowledge gap and inform evidence-based recommendations and counseling
regarding the potential risks of cannabis consumption in the postpartum period and while lactating.

Public health relevance
In this study focusing on cannabis use in the postpartum period, we will evaluate the associa�on between maternal cannabis use and maternal atachment and bonding. Addi�onally, we will evaluate the transfer of cannabis metabolites to infants through breas�eeding. This will provide much needed informa�on to inform evidence-based counseling and recommenda�ons regarding cannabis use in the postpartum period.